Novel role of mitochondrial carrier protein PSAP in regulation of both apoptosis and autophagy in ALS

Amyotrophic lateral sclerosis (ALS) is one of most devastating neurodegenerative disorders characterized by
the degeneration of motor neurons, paralysis, and often accompanied by cognitive dementia. In addition to
genetic mutations, the biggest risk factor for ALS is aging. Although dysregulation of apoptosis and
mitochondrial quality control, and impaired autophagy, the fundamental physiological processes crucial for
maintaining cellular homeostasis, have been identified as playing pivotal roles in the pathogenesis of ALS, the
mechanisms underlying the dysregulation of these processes remain elusive. Using the superoxide dismutase
1 mutant (SOD1G93A) mouse model of ALS, our preliminary data intriguingly revealed that knockout of PSAP
(presenilin-associated protein), also known as MTCH1, which was originally identified as a mitochondrial
proapoptotic protein by our group, greatly improved motor function and extended the lifespan of the SOD1G93A
mice. These novel findings led to this proposal to investigate the molecular mechanism whereby PSAP
contributes to the pathogenesis of ALS. Furthermore, our data revealed a significant decrease in the activation
of caspase-3 and the levels of p62-positive inclusion bodies in the spinal cord of SOD1G93A mice upon PSAP
knockout, implying that PSAP knockout exerts a neuroprotective effect by inhibiting apoptosis and enhancing
autophagic activity. Moreover, our study discovered that PSAP interacts with voltage-dependent anion channel
1 (VDAC1), a protein known to play a crucial role in regulating both apoptosis and autophagy. Additionally, our
study has demonstrated that PSAP interacts with death receptor 6 (DR6), which has been implicated in
transducing the pathogenic effect of toxic factors secreted by astrocytes expressing SOD1G93A. These novel
findings lead to this proposal to elucidate the molecular mechanism by which PSAP contributes to the
pathogenesis of ALS. We hypothesize that PSAP functions as a key molecule to bridge cell surface receptor
DR6 and mitochondrial VDAC1, establishing a distinctive mitochondrial pathway to mediate the toxic effects of
factors released by neighboring cells, such as astrocytes expressing SOD1G93A, leading to neurodegeneration
by dysregulating both apoptosis and autophagy. Using our novel global and motoneuron-specific PSAP-
knockout mouse models, the proposed study will investigate the pathological role of PSAP in ALS, specifically,
focusing on disease-related apoptosis and autophagy in vivo. Moreover, using our newly established novel
PSAP-knockout cell line in motoneuron-like NSC34 cells, we will further elucidate the novel molecular
mechanism underlying the regulatory role of PSAP in apoptosis, autophagy, and mitochondrial quality control
under relevant stress conditions in vitro. The success of the proposed study will yield novel insights into the
molecular mechanism underlying the pathogenesis of ALS and lead to the identification of new therapeutic
targets for developing effective treatment strategies against ALS and other neurodegenerative disorders.
Therefore, the proposed study holds significant translational value and high impact in the field of ALS research.

Public health relevance
Project Narrative The goal of this proposal is to elucidate the novel mechanism underlying the pathogenesis of amyotrophic lateral sclerosis (ALS). Based on our novel findings, we hypothesize that the mitochondrial carrier protein PSAP plays a regulatory role in mitochondrial quality control, apoptosis, and autophagy pathways, thereby contributing to the pathogenesis of ALS and other neurodegenerative diseases . The elucidation of the molecular mechanisms underlying the pathogenesis of ALS will facilitate the development of preventive and therapeutic strategies .